GROWTH AND SEXUAL MATURATION IN CHILDREN WITH SICKLE CELL DISEASE

Determine cause of growth failure and delayed puberty in children with sickle cell anemia using hormone measurements and human chronic gonadotropin stimulation. Results correlated with severity of primary disease.